Decreased smooth muscle cell force generation contributes to thoracic aortic disease via altered focal adhesion dynamics, composition, and signaling

PROJECT SUMMARY – PROJECT 1
The majority of genes with pathogenic variants that confer a highly penetrant risk for heritable thoracic aortic
disease (HTAD) lead to aberrant smooth muscle cell (SMC) - extracellular matrix (ECM) interactions and are
predicted to compromise SMC homeostatic force generation. By contrast, we hypothesize that the normal
structure of the aortic medial layer allows the SMCs to generate basal levels of tension across elastic-contractile
units (ECUs) to maintain a homeostatic state such that normal mechanosensing focal adhesions (FAs) are not
activated (i.e., they are quiescent at basal levels). Pathogenic variants in HTAD genes that decrease SMC
contractile force generation activate FA kinase (FAK) signaling through altered FA-ECM composition and
dynamics, thus triggering distinct downstream pathways, with Rho/ROCK signaling and hypercontractile
actinomyosin motors allowing aneurysm formation and the addition of mTOR signaling driving progression to
dissection. We will initially determine, in collaboration with Project 3, how the loss of force generation in Acta2-/-
SMCs alters the composition and dynamics of FA-ECM interactions and alters downstream signaling pathways.
Altered ECM composition, along with manipulation of FAs and downstream signaling pathways, will rigorously
test how altered FA-ECM interactions drive specific downstream signaling. We will also assess changes FA-
ECM composition and FAK-driven signaling in Prkg1R177Q/+ mice associated with slowly enlarging aneurysms
versus acute dissections, including a hypertensive challenge to complement Projects 4-5. Specific FA-driven
pathogenic or protective pathways will be targeted with drugs or genetic manipulation to confirm their role in
disease progression. Finally, the role of developmental or chronic versus acute changes in FA-ECM composition
in triggering dissection will be assessed by varying timing of conditional knock-in of Prkg1R177Q/+ variant in SMCs,
thus complementing work in Project 2. Thus, this Project will address a critical knowledge gap of the role of SMC
mechanosensing in thoracic aortic disease by focusing on FA-ECM dynamics and structure, along with
downstream signaling, when force generation across FAs is disrupted by variants in genes encoding proteins
involved in SMC contraction. Since FAK activation of Rho/ROCK may be an adaptive change that maintains
SMC homeostasis (e.g., mean wall stress, see Overall Project) while allowing aneurysm growth and delaying
ascending dissections, it will be contrasted with FAK activation of mTOR signaling, which augments TAD
progression to dissection. In this way, we will complement studies in Projects 2-5 to collectively identify new
therapeutic targets, including FA-driven signaling pathways to prevent dissections.